Understanding the immune response changes to clinical interventions for Epstein-Barr virus infection prior to lymphoma development in children after organ transplants (UNEARTH)

Abstract/Summary
Among the Epstein-Barr virus associated cancers is post-transplant lymphoproliferative disease (PTLD), a rare
but major complication of pediatric solid organ transplants (SOT). Many children are EBV-seronegative at time
of SOT, leading to primary EBV infection from the allograft under intense immunosuppression, and a higher
chance of a chronic high viral load (CHVL) state or PTLD. Longitudinal peripheral blood EBV DNA nucleic acid
testing (NAT) has not improved the individual prediction of PTLD occurrence, likely due to variable SOT recipient
immune responses. Further, these patients receive clinical interventions for EBV DNAemia, with incomplete
responses for unknown reasons. Our team of SOT, infectious disease and immunology professionals will bring
new and complimentary expertise to close these knowledge gaps. We will perform longitudinal T and NK cell
immune function assays in conjunction with local and central EBV and anellovirus NAT in 1390 samples across
5 time points in the first year after 278 SOT (kidney, liver, heart, lung or intestine) at 3 major children's hospitals.
We will accomplish the following Specific Aims, comparing thoracic and abdominal SOT recipients with primary
EBV infection or CHVL state: 1. Assess the prospective phenotypic and functional features of T cell
“exhaustion” and correlate with EBV infection outcomes and NK cell profile. Hypothesis: SOT recipients'
that develop CHVL state display distinct phenotypic memory differentiation and exhausted CD8+ and CD4+ T
cell profiles that are regulated by distinct inflammatory circuits. We will accomplish this aim by performing multi-
spectral flow cytometry to characterize T cell phenotype and function, as well as Meso Scale Discovery platform
to assess distinct viral control-relevant plasma cytokines/chemokines, during the phases of initial replication,
expansion, progression, CHVL or recovery states. 2. To prospectively define the number, phenotype, and
functional status of NK cells, and correlate with EBV infection outcomes. Hypothesis: NK cell activation
will coincide with primary infection, and will correlate positively with clearance vs. negatively with persistent EBV
replication. NK cell dysfunction will develop in patients with CHVL, who are at highest risk of PTLD. We will
leverage our established multi-spectral flow cytometry panel and analyze patients with primary EBV infection
after SOT and answer questions related to the activation status, NK receptor repertoire, and functional capacity.
3. Determine the association of peripheral blood torquetenovirus (TTV) DNA loads to EBV outcomes, T
and NK cell profiles. Hypothesis: TTV loads reduce with clinical reductions in immunosuppression and predict
EBV clearance. We will accomplish this aim using longitudinal whole blood NAT assays for both viruses at
common time points, performed centrally to minimize lab variability. By study end, we will know the T and NK
immune responses to EBV across multiple clinical situations. We expect to find key immune mechanisms that
will predict poor or delayed EBV clearance despite clinical interventions, which may lead to new translational
immunotherapy approaches to prevent PTLD, or inform EBV oncogenesis in other populations.

Public health relevance
NARRATIVE Post-transplant lymphoproliferative disease (PTLD) is a group of rare malignant complications of solid organ transplant that include Hodgkin disease and non-Hodgkin lymphoma. About 50-80% are associated with Epstein-Barr virus (EBV) infection, yet the T cell and Natural Killer cell immune responses in primary EBV infection in children or during progression to PTLD are not well characterized. By performing detailed prospective immunological phenotyping through the first year after 278 pediatric organ transplants, we will unearth pathways that may inform EBV oncogenesis progression in immunocompromised populations.